Sustained Release Relaxin-2 for the Treatment of Frozen Shoulder

PROJECT SUMMARY/ABSTRACT
This proposal describes an innovative and restorative treatment for shoulder arthrofibrosis, also known as frozen
shoulder. Of the 15 million individuals in the United States suffering from shoulder arthrofibrosis, more than 1.6
million seek medical care each year. Current treatment options, including intraarticular corticosteroid injections,
non-steroidal anti-inflammatory drugs (NSAIDs), and nerve blockers, provide only marginal and temporary relief
of patient symptoms and do not address the underlying cause of the disease – the accumulation of fibrotic
collagenous tissue. Physical therapy is a main treatment option but it is prolonged and suboptimal. Surgical
interventions are used in severe cases, but these procedures are fraught with complications and can further
aggravate the fibrosis. We propose the use of human relaxin-2 (RLX) as a novel therapeutic for the treatment of
shoulder arthrofibrosis. RLX is an endogenous 6-kDa peptide hormone that primarily aids in softening of the
pubic symphysis and pelvic ligaments prior to childbirth via extracellular matrix remodeling. Repurposing this
antifibrotic peptide to treat arthrofibrosis represents a first-of-its-kind protein therapy for this disease.
Specifically, we describe detailed mechanism-of-action studies for RLX in the joint space combined with
encapsulation and sustained delivery of RLX from microparticles prepared from both novel and well-established
biocompatible and biodegradable polymers. The proposed experiments will define the molecular and
structural basis for RLX signaling in the joint space and will use an in vivo shoulder joint contracture
immobilization model to test the hypothesis that RLX reduces arthrofibrosis by inhibiting TGF-β1
signaling via the NO-sGC-cGMP pathway, thereby decreasing joint stiffness and increasing shoulder
range of motion (ROM). Further, we hypothesize that sustained release of RLX from a single intraarticular
injection of RLX-loaded polymeric microparticles will alleviate both the symptoms and causes of arthrofibrosis.
Importantly, preliminary data support the proposed studies, well-characterized materials and rigorous
experimental designs are established, and essential cross-disciplinary collaborations and expertise are in place
to address the hypotheses. The specific aims of this five-year proposal are as follows. Aim 1 defines the
molecular mechanism of by which RLX binds its receptor, RXFP1, providing a framework for structure-based
optimization of RLX. Aim 2 determines the material property characteristics of RLX-loaded biodegradable and
biocompatible polymeric microparticles, including RLX release kinetics and particle degradation. Aim 3 assesses
the pharmacokinetics and efficacy of the optimal RLX-loaded microparticle formulation identified in Aim 2 using
an established in vivo shoulder contracture model.

Public health relevance
PROJECT NARRATIVE Reduced shoulder mobility caused by prolonged joint immobilization, trauma, or surgical procedures is painful and debilitating. Current pharmacological and surgical treatment options for patients suffering from shoulder arthrofibrosis, or “frozen shoulder,” are limited in scope and effectiveness, resulting in many patients never regaining full joint function. The sustained and localized delivery of the antifibrotic peptide hormone, relaxin-2, is described as a novel solution to treat the underlying causes of shoulder contracture and to restore joint range of motion.